CORE--TRANSGENIC ANIMAL FACILITY

The Transgenic Animal Core Facility (TAC) provides interactive support to DERC investigators in the theoretical and technical aspects of the introduction of cloned, genetically engineered DNA into the cells of living animals. This technology allows the investigators to biological and disease processes.